Biostatistics Core - RC1

RC1 – Biostatistics Core: Project Summary
Since mid-2003, this OAIC Biostatistics Core (RC1) has dedicated critically needed resources toward the
quantitative challenges of research on frailty. Partnering in OAIC leadership, and working closely with other
OAIC resource cores, it has helped develop the careers of an interdisciplinary cohort of junior faculty
supported by the Research Education Component (REC)—and beyond—and ensured expert design and
analysis of pilot, external, and de novo studies needed to advance science on frailty. It now proposes to
continue in these efforts, by providing: (1) mentorship for junior faculty supported by our REC, and our
broader OAIC, in developing careers focused on frailty and aging; (2) new data and computing infrastructure
and software, including web-based data housing and acquisition tools; (3) expertise for science on frailty,
through support for the design, statistical analysis, and data management of research projects, and through
making available new data analytic methodologies that are essential to studying the complex syndrome of
frailty; and (4) leadership and visibility for frailty-related scientific and health promotion endeavors at Johns
Hopkins, throughout the OAIC network, and in the broader gerontological community. Our support and
leadership in these areas have been significant and wide-reaching, and could not be provided without the
resources of this Core. The leadership is experienced, expert, deeply immersed in scholarship on aging, and
visible in both gerontology and statistics. The Core will continue to support every REC and pilot-supported
investigator as per their need. The Core synergizes actively with other OAIC resource cores, as evidenced by
progress over the last cycle. Our team includes a statistical genomics expert to enhance our collaborations
with the Biological Mechanisms Core (RC2). We also have engaged an internal consultant with expertise in
signal intensive measurement to enhance our interactions with our new Technological Assessment and
Solutions Core (RC4). We will continue to provide design and analytic expertise and support a Registry
collaboratively with the Clinical Translation Core (RC3). Regarding new methodologies: research will develop
approaches needed to better (i) assess prefrailty, hence identify at-risk persons early enough to intervene
successfully; (ii) delineate heterogeneous etiology underlying frailty; (iii) design studies to assess frailty
intervention; (iv) characterize attributable fraction of frailty risk factors over the lifecourse, and (v) address
frailty disparities. By efforts along all these lines, this Core will contribute crucially to the success of this OAIC
in answering a next generation of questions on frailty, and achieving findings' translation toward increased
independence of older persons.